The regulation of synaptic transmission and neural circuit function

The lab is interested in understanding molecular and cellular mechanisms underlying synapse formation and synaptic plasticity, and in the long term elucidating synaptic mechanisms underlying neuronal circuit function in animal behavior. We believe that these studies will provide fundamental insights into neural underpinnings for brain cognition, and will identify synaptic and neural circuit malfunctions that are involved in many neurological and mental disorders, such as epilepsy, Alzheimer's disease, depression and autism. Specifically, during the 2019 fiscal year, we have made following progress: For research Aim 1, we have identified a novel auxiliary subunit of GABA-A receptors. Currently a manuscript describing this work has been accepted for publication in Science (In press). For research Aim 2: we have made important progress in determining the molecular mechanisms underlying GABAergic synapse development. Currently two manuscripts have been published during the fiscal year of 2019 (one is in press). These studies reveal a critical role of GABA-A receptors in establishment of GABAergic, but not glutamatergic, synapses during development, and a key role of Slitrk3 C-terminus in constructing inhibitory connections. In addition, we have determined how trans-synaptic interactions regulate GABAergic synapse development. Currently a manuscript describing this work is under preparation and will be submitted in a few months. Furthermore, we have made progress in understanding NMDAR-mediated signaling for GABAergic synaptogenesis. Finally, during the 2019 fiscal year, we have collaborated with Dr. Katherine Roche group at NINDS, NIH to study the function of Neuroligin1-PSD95 interaction, which led a publication in PNAS, and have collaborated with Dr. Samarjit Bhattacharyya at IISER, India, to study metabotropic glutamate receptor trafficking, which led a manuscript that has been submitted for publication. In addition, we have collaborated with Dr. Chris McBain at NICHD, Dr. Ron Petralia at NIDCD, Dr. Ling-Gang Wu at NINDS, Dr. Chengyu Liu at NHLBI, and Dr. Joseph Lynch at University of Queensland to study a novel GABA-A receptor auxiliary subunit, which led to a publication in Science (In press). We have also collaborated with Dr. Yelin Chen at Chinese Academy of Sciences working on a review article on NMDA receptors, which led to a publication in Brain Science Advances.